Development of Oral KCC2 Potentiator AXN-027 as a Novel Anti-Epileptic Drug for Mesial Temporal Lobe Epilepsy

Development of oral KCC2 potentiator AXN-027 as a novel anti-epileptic drug for mesial
temporal lobe epilepsy
Abstract:
Patients with mesial temporal lobe epilepsy (mTLE) have spontaneous recurrent seizures (SRS) that are often
refractory to commonly used antiepileptic drug (AEDs). New targets and therapies are thus urgently required to
address this drug resistance in ~40% of patients. Loss of excitation/inhibition (E/I) balance in neuronal circuits is
a pathological hallmark of epilepsy. KCC2 is a CNS-specific potassium/chloride cotransporter that maintains low
intracellular chloride in neurons, and is critical for enabling GABAergic inhibition. However, KCC2 hypofunction
occurs in patients with both idiopathic and acquired epilepsy, while KCC2-deficient mice have increased seizure
susceptibility and mTLE pathologies. The resulting abnormally high chloride in neurons is thought to lead to
pathological excitatory responses to GABA, and limit efficacy of GABA-acting AEDs. Increasing KCC2 function
via genetic, viral and pharmacological approaches protects against epileptic seizures in vivo and in vitro.
Therefore, a KCC2-potentiating treatment could restore E/I balance, rescue pharmacoresistance, and treat SRS
in mTLE patients. But there are no FDA-approved drugs that selectively potentiate KCC2.
AXONIS’ are developing proprietary compounds that selectively potentiate KCC2 function by binding to
KCC2, increasing KCC2 surface clustering, and increasing KCC2 chloride extrusion. AXONIS’ lead KCC2
potentiator, AXN-027, is a highly optimized orally-bioavailable compound selected from extensive structure-
activity relationship work driven by potency and CNS-favorable ADME/PK properties. In this Phase 1 SBIR, we
will use a well-characterized intrahippocampal kainate-induced mouse model of mTLE with chronic SRS and
electroencephalogram (EEG) to investigate anti-seizure efficacy of AXN-027, which will enable development of
a first-in-class KCC2-potentiating AED to treat mTLE patients.

Public health relevance
Project Narrative: One-third of mesial temporal lobe epilepsy have spontaneous recurrent seizures that are often resistant to commonly used antiepileptic drugs. Loss of excitation/inhibition balance in neuronal circuits is a pathological hallmark of epilepsy, and KCC2 hypofunction occurs in epilepsy patients. We are developing a novel orally administered drug targeting KCC2 that acts to rebalance the neuron activity within the brain, without sedative side effects, in order to treat seizures, address drug-resistance, and improve quality of life of epilepsy patients.